Neuronal Primary Cilia Dysfunction in Tuberous Sclerosis Complex

Tuberous sclerosis complex (TSC) is a genetic disorder caused by heterozygous inactivating variants in TSC1
or TSC2. TSC is characterized by the growth of benign tumors in multiple organs, as well as neurological
manifestations such as refractory epilepsy, autism spectrum disorder, and intellectual disability. TSC1 and
TSC2 form a protein complex with TBC1D7 that acts as a key upstream negative regulator of the mechanistic
target of rapamycin complex 1 (mTORC1), and mTORC1 hyperactivation is thought to be a key pathogenic
driver of TSC. Treatments that inhibit mTORC1 cause arrest or regression of tumors in TSC but have shown
limited efficacy in treating epilepsy and no efficacy in treating the neurocognitive symptoms of TSC.
Consequently, there is a substantial unmet need for the development of new therapeutics, which will require
further understanding of the molecular mechanisms of neurological symptoms in TSC. Among the several
downstream consequences of mTORC1 dysregulation, disruption of primary cilia has emerged as one potential
candidate for mediating neuronal dysfunction in TSC. The primary cilium is an immotile organelle that extends
from the plasma membrane and contains a distinct composition of transmembrane receptors, rendering it a
signaling hub. Our work has shown that in TSC, neurons are less often ciliated, and the remaining cilia are
significantly lengthened. Accordingly, in the proposed research the applicant aims to investigate the molecular
mechanisms underlying these alterations. Preliminary data suggests that upregulation of HSP27 in astrocytes
may be a non-cell autonomous modulator of neuronal cilia in TSC. Therefore, in Aim 1 we propose to
determine whether astrocytic expression of Hsp27 is necessary and/or sufficient to modulate cilia in Tsc1-
deficient neurons. To enhance the translational relevance of this work, in Aim 2, we will evaluate neuronal
primary cilia and astrocytic HSP27 expression in human cells. Our finding of altered neuronal cilia morphology
in TSC also raises the question of whether cilia are functionally impaired. Our preliminary data suggests that
ciliary calcium channels are differentially expressed in neurons in TSC, so in Aim 3 we will characterize ciliary
calcium signaling in Tsc1-deficient neurons. mTOR dysregulation and cilia dysfunction are common
observations across several disorders that display high rates of epilepsy and/or autism, making the proposal
an excellent project to introduce the applicant to neurodevelopmental disorders and to broaden the impact of
this research. The proposal contains a comprehensive training plan for the applicant to become a productive
independent investigator, including plans to obtain key technical skills in stem cell culture and calcium imaging,
and to increase presentation and publication opportunities. The research outlined in this proposal will take
place at Boston Children’s Hospital (BCH) in the lab of Dr. Mustafa Sahin, an expert in the neurobiology of
TSC. The institutional environment at BCH, including talented scientists and abundant resources and
equipment, together with the mentorship of Dr. Sahin, will support the evolving needs of this project.

Public health relevance
Tuberous sclerosis complex (TSC) is a genetic disorder with high rates of epilepsy, autism spectrum disorder, and intellectual disability, but the cellular mechanisms underlying these neurological symptoms are not well understood. We have found that the primary cilium, a sensory organelle, is altered in neurons of TSC patients. In this study, we will investigate the molecular mechanism underlying this alteration and its functional implications.